Mathematical Modeling Core

Summary – Mathematical Modeling Core
HIV infection remains an important public health problem. Effective antiretroviral therapy (ART) can
control the infection, but lifelong ART is challenging and is encumbered by long-term adverse drug
effects. The major challenge to eradicating HIV-1 is the existence of the long-lived latent HIV-1 resevoir.
While reservoir eradication is the ultimate goal, to achieve that goal we need greater understanding of
the factors underlying the establishment of the reservoir, the composition of the reservoir, the dynamics
of the reservoir and if there are specific properties of reservoir cells that could be exploited to enhance
their elimination. Following the initiation of ART, the amount of virus in the blood drops dramatically.
This is due to the fact that most infected cells die very quickly, and when new infection events are
blocked by ART, this decay becomes apparent. However, not all of the infected cells die; some survive
and may become part of the stable latent reservoir. This research program will study these decay
processes using precise quantitative assays and single cell techniques in hope of understanding
whether the decay represents a selection process that shapes the composition of the latent reservoir.
The Modeling Core will develop mathematical models to explain these decay processes and how they
are related to the dynamics of the latent reservoir. The Core will also provide expertise in experimental
design and analysis of experimental results. We hope that this collaborative, quantitative approach will
lead to a better understanding of how the reservoir forms and persists and to novel cure strategies.